Investigating Histone Acetylation Modulator Function in Alveolar Regeneration and Disease Pathogenesis

Project Summary
Influenza and COVID-19 remain significant global health concerns, with viral infections in the lungs often
leading to alveolar damage and, in severe cases, progressing to acute respiratory distress syndrome (ARDS).
ARDS development is closely linked to impaired alveolar regeneration, which relies on the proliferation and
differentiation of alveolar type 2 (AT2) stem cells into alveolar type 1 (AT1) cells to restore lung function. The
precise molecular mechanisms that govern alveolar regeneration remain poorly understood. Here I have
established a high-throughput in vivo genetic screening system in mice to systematically search for essential
epigenetic modulators that contribute to alveolar regeneration. Preliminary results have identified numerous
histone acetylation pathway related genes, including lysine acetyltransferase 8 (Kat8), are required for AT2
restoration and may contribute to differentiation towards AT1 cells. Kat8 has not previously been linked to
alveolar regeneration, however, a key component of its associated protein complex and downstream target
genes has been identified in genome-wide association studies as risk genes for idiopathic pulmonary fibrosis, a
deadly disease also caused by impaired alveolar regeneration. This proposal aims to clarify the mechanisms
by which Kat8 regulates alveolar regeneration, determine the association of Kat8 loss of function with
pulmonary fibrosis and further enhance the existing in vivo screen system by integration with single cell
techniques to comprehensively map other histone acetylation modulation functions. This study will shed light
on epigenetic mechanisms underlying AT2-mediated alveolar regeneration and disease pathology, with the
potential to inform the design of novel therapeutic approaches targeting histone acetylation modulators to
promote alveolar regeneration and combat fibrosis progression. The proposed research plan will be executed
at the Broad Institute of MIT and Harvard, Cambridge, under the mentorship of Dr. Fei Chen and Dr. Jayaraj
Rajagopal, with overall complementary expertise in the field of genomics, synthetic biology, and lung stem cell
biology. My career objective is to become a tenure-track faculty pioneering and simultaneously training
next-generation scientists at the intersection of technology and lung stem cell biology. To accomplish my career
goals, I have put together a comprehensive training plan to enhance the overall skill sets required to establish
myself as a successful independent investigator. To ensure timely progress toward fulfilling my rigorous
research plan and career goals, I have gathered an expert advisory committee comprising Dr. Carla Kim, Dr.
Darrell Kotton, Dr. Jason Buenrostro, and Dr. Ruth Franklin, with whom I will regularly discuss my research
progress and receive invaluable career development guidance, the key ingredient to my pathway to scientific
independence.

Public health relevance
Project Narrative Acute respiratory distress syndrome (ARDS) is a severe complication that significantly contributes to influenza and COVID-19 mortality. ARDS development is closely associated with impaired alveolar regeneration, but the molecular mechanisms remain poorly understood. This proposal will uncover the epigenetic mechanisms underlying alveolar regeneration, paving the way to identify novel therapeutic targets to enhance regeneration and combat disease progression.